Multiscale analysis of HIV-1-induced small T cell syncytia

HIV-1 dissemination critically depends on migration of infected T cells. Unexpectedly, a fraction of the infected
T cells was recently found to exist as small syncytia, containing up to four nuclei. Importantly, these entities
differ from larger syncytia which sometimes can be observed in late stages of virus
dissemination/pathogenesis. Indeed, and as shown in three independent intravital imaging studies, they are
present already at the earliest stages of infection. Our analyses in physiologically relevant in vitro settings
further documented that small T cell syncytia can transfer virus to uninfected cells, suggesting that they can
contribute to early virus dissemination.
With this R01 application, we propose to start exploring whether HIV-1-induced small syncytia can indeed
directly contribute to virus spread. We will start our investigations by characterizing motility/migration properties
of syncytia and analyzing their role in virus transmission dynamics. Host and viral factors involved in
homeostatic maintenance of the syncytial compartment will also be studied. Importantly, we have recruited the
support of a leading HIV proteomics lab in order to comprehensively map the expression profiles of syncytia.
Should the data resulting from this work support the hypothesis that syncytia contribute significantly to virus
dissemination, we will pursue further funding in order to study potential strategies against these entities.

Public health relevance
HIV/AIDS remains an important public health problem. Investigations aimed at understanding how HIV disseminates in infected individuals and how its mode of spread contributes to establishment of latency and pathogenesis may reveal novel targets for intervention.